REGULATION OF EXPRESSION AND FUNCTION OF NEUROPEPTIDES DURING DEVELOPMENT

The role of local interactions in the diversification of neuropeptide phenotypes was studied in developing Xenopus brain, using in situ hybridization histo-chemistry. A highly localized appearance of pro- opiomelanocortin (POMC) cells was observed in the pituitary and forebrain suggesting the existence of a common POMC precursor that is anterior most in the neural plate. In another neuropeptide phenotype TRH, the pattern spanning adult forebrain, comprising over six different nuclei arise from a dispersed population that is highly regionalized embryonically. Thus a subset of phenotypically distinct neuronal cells develops as a group before distinct forebrain nuclei form, arguing specific neuronal cell fates may be dictated by cell lineage or local induction. The developmental expression of GnRH-I was also studied. Unlike POMC and TRH, GnRH-I was suppressed until metamorphic climax. GnRH cells were first detected after they reached their final position in the preoptic area during the late larval period. A fragment of Xenopus PC2, a prohormone converting enzyme was cloned by PCR and the cDNA used in in situ hybridization as a second phenotypic marker for neuropeptide cells. PC2 was found to be expressed in a highly localized region specific pattern which included TRH neurons. The expression of a new LIM-class family of homeobox genes was characterized from embryo to adult Xenopus CNS. It was found that the Xlim-3 gene was expressed in frog pineal, pituitary, hindbrain and retina. However, it was not expressed in a specific subset of cells in the anterior pituitary or pineal. Xlim-1 was expressed in certain more posterior forebrain nuclei and the expression pattern could include some forebrain cells that express TRH and GnRH, but not POMC. The LIM-class homeobox genes may be involved in the specification of brain cytoarchitecture corresponding to individual brain nuclei including ones expressing specific neuropeptide genes.